RR&D Research Career Scientist Award Application

Dr. Patten's research focuses on understanding the neural basis of human movement. The overarching goal
of her translational research is to improve the quality of clinical neurorehabilitation through development of
effective, efficient, targeted interventions that promote recovery of neuromotor function. Informed by extensive
clinical experience as a physical therapist, her research bridges the fields of neurorehabilitation,
neuromechanics, and neuroengineering to conduct quantitative, mechanistic investigation with three related
objectives: 1) elucidating mechanisms of movement dysfunction with aging and in adult neuropathologies; 2)
determining capacity for motor recovery following central nervous system injury; and 3) identifying critical
factors that contribute to rehabilitation efficacy. To achieve these goals, the programmatic lines of her
research investigate: a) neural mechanisms and biomechanical consequences of CNS pathologies causing
motor dysfunction, b) development of biomarkers of motor recovery, and c) novel means to induce
neuroplasticity and motor recovery. Dr. Patten's research influences clinical care in neurorehabilitation, thus
helps individuals with motor dysfunction resulting from neuropathologies, such as stroke, maximize recovery,
restore activity participation, and optimize quality of life.
Dr. Patten has studied adults with stroke-related motor dysfunction for over 20 years. She has been the
Principal Investigator for four VA-RRD supported clinical trials investigating effects and response to
rehabilitation interventions for persons post-stroke [VA RRD B2450R, VA RRD B29792R, VA RRD B3964R,
VA RRD B540231]. Results of these studies have been influential for the field and have been incorporated into
clinical practice guidelines and recommendations such as the Evidence-based Review of Stroke Rehabilitation.
Observation of responders and non-responders to therapeutic intervention —without baseline differences in
clinical characteristics— motivated investigation of intrinsic physiological differences among these sub-groups,
for which she conducted in cross-sectional studies of chronic stroke survivors (VA RR&D 1I21RX-1435-0]).
This work motivated a subsequent VA RR&D Merit Review (I01RX001677), which she currently conducts as
PI, to examine plantarflexor corticospinal efficacy as a potential biomarker for walking recovery. Additionally,
she is the Site PI for a multi-site study (R01NR015591) tracking biomarkers of stress and genetic variation
collected in the acute period following stroke to determine how these may inform heterogeneity in response to
rehabilitation. She also collaborates, as a Co-I (1R01AG054621-01) on studies using high-density EEG to
understand brain dynamics in elders in response to perturbations during locomotion. Finally, a new study
supported by the NSF (M3X, #1935501) will enable deeper understanding of the process of human motor
learning, plasticity, and transfer to behavioral, neuromechanical effects.
The current application is for renewal of Research Career Scientist support to Dr. Carolynn Patten, a non-
clinician Investigator, with over 20 years of uninterrupted research support through the VA Rehabilitation R&D
service. Dr. Patten is dual-appointed (5/8 VA) between VA Northern California Health Care System
(VANCHCS) and University of California, Davis, where she is a Professor (tenured) in the Departments of
Physical Medicine & Rehabilitation (School of Medicine) and Neurobiology, Physiology & Behavior (College of
Biological Sciences). In July 2018 Dr. Patten transitioned to her current position at UC Davis and VANCHCS
from Malcom Randall VA Medical Center (Gainesville, FL) and VA Brain Rehabilitation Research Center
(BRRC) where she was dual-appointed between MRVAMC / BRRC (6.6/8 VA) and University of Florida where
she held the rank of Professor (tenured) in the Department of Physical Therapy. Dr. Patten was recognized as
a University of Florida Research Foundation Professor in 2015 and was inducted as Catherine Worthingham
Fellow of the American Physical Therapy Association, the profession's highest academic honor, in 2016.

Public health relevance
Over 15,000 Veterans are hospitalized for stroke annually, leading to combined costs for acute, post-acute, and follow-on care exceeding $274 million. As the baby boom generation (individuals born from 1946-1964) ages, the prevalence of stroke in Veterans is anticipated to more than double. While stroke can occur at any age, stroke risk doubles by decade after age 55. Male Veterans, who currently average 64 years of age, reveal an 81% increased stroke risk compared to non-veteran age counterparts. Due to the significant impact of stroke on quality of life, improvements in prognosis, intervention, and clinical care are therefore critical to the future of Veterans' healthcare. The large proportion of baby boom era Veterans, disproportionately represented by males with substantially elevated stroke risk, underscores the importance of accelerating discoveries that will maximize recovery, restore activity participation, and optimize quality of life for Veterans with stroke-related disability. Resulting advances in neurorehabilitation will place the VHA at the forefront of this critical healthcare need.